SOLUTION STRUCTURE OF PLATINUM MODIFIED DNA DUPLEX

Interproton distances commonly used in solution structure refinements of biological macromolecules are measured by the nuclear Overhauser effect (nOe), typically observable only for interproton distances <5 [unreadable]. The lack of longer-range distance constraints (>>5[unreadable]) does not normally affect the solution structures of proteins since folding brings distant primary sequence residues within 5 of each other. In duplex DNAs and some RNAs, however, the secondary structure is primarily one-dimensional with protons on each residue exhibiting nOe's only to protons on adjacent residues in primary sequence or within base-pairs. The lack of tertiary structure, coupled with the inability to determine long-range distance constraints, leaves the solution structures of many duplex oligonucleotides underdetermined. To address this concern, we have site-specifically modified a duplex undecamer (dCTCTCGGTCTC~GAGACCGAGAG) with cis-[Pt(NH3)(4AT)Cl2] (where 4AT=4-aminoTEMPO). This platinum compound is a paramagnetic analog of the potent anticancer agent cis-[Pt(NH3)2Cl2], cisplatin. Incorporation of a stable unpaired electron into an otherwise diamagnetic system induces distance-dependent relaxation of each proton by the localized unpaired electron spin density. Our work focuses on the analysis of this relaxation to determine long-range (~10-20[unreadable]) electron-proton distances in this paramagnetic duplex. Restrained molecular dynamics refinements of this DNA structure constrained with these long-range distances in addition to interproton (nOe) distances are in progress to determine the distortion of the dna duplex which is induced upon platinum-binding.